Mechanisms of antibody-mediated lung Injury after blood transfusion

PROJECT SUMMARY/ABSTRACT
Blood transfusions are life-saving for many patients with blood loss or blood production defects, but there are
complications that limit their effectiveness and/or lead to medical sequelae. One such sequela is the
development of acute lung injury, or transfusion-related acute lung injury (TRALI). TRALI has long been the
number one cause of transfusion-related death and a major contributor to in-hospital morbidity. The
pathogenesis of TRALI is incompletely understood, but there is consensus that TRALI is a classic example of
antibody-mediated disease with a prominent role of HLA/MHC antibodies present in the donor blood product
inciting lung injury in susceptible recipients. Indeed, we have developed a mouse model of TRALI based on
transfusion of MHC Class I antibody into mice expressing the cognate MHCI antigen. In this application, we will
use this model as a platform to investigate three specific aims. In Aim 1, we will determine the critical site of
cognate antigen expression required to initiate TRALI by testing mice that are engineered to be deficient or
sufficient in antigen expression in specific cellular locations. Novel mouse tools will be used to selectively delete
Class I expression (B2mfl/fl) or selectively express allo-Class I protein (Con-Kd) on the endothelium or on specific
immune cells. Using these complimentary mouse tools, we will definitively address the critical site of antigen
expression required to initiate TRALI. In Aim 2, we will turn our attention to the biochemical characteristics of
antibodies associated with the induction of TRALI. A single mouse monoclonal antibody against Class I (34-1-
2S) has been described to produce TRALI, whereas many other antibodies against the same antigen do not
cause TRALI; it is unclear why this antibody is unique in its pathogenicity. We will test the hypotheses that
antibody affinity, IgG subtype, glycosylation, and cross-reactivity each influence the induction of TRALI. These
studies will utilize cutting-edge antibody engineering and binding and affinity assays to determine the properties
of antibodies that impart pathogenicity in TRALI. In Aim 3, we will focus on the downstream events resulting
from antibody engagement and recognition by immune cells. FcγRs are immune receptors that are the proximal
trigger of antibody-mediated immune responses. Using a new mouse model that allows for the conditional
deletion of activating FcγRs (Con-Fcγ-KO), we will determine the critical cells responsible for antibody recognition
in TRALI. We will further determine if an inhibitory FcγR (FcγRII) influences TRALI severity. Finally, we will
humanize the 34-1-2S antibody and infuse it into mice engineered to express human FcγRs in the absence of
murine FcγRs. 34-1-2S will be expressed as each of the different human IgG subtypes (IgG1-IgG4) testing the
hypothesis that IgG subtype affects TRALI in humans. The results of these experiments will definitively map the
cells, antibody determinants, and receptors that are critical to TRALI induction. This knowledge will aid in our
understanding of this serious complication of transfusion therapy and inform translational strategies to prevent
or treat TRALI.

Public health relevance
PROJECT NARRATIVE Blood transfusions are life-saving, but complications do result, including damage to the lungs termed transfusion- related acute lung injury (TRALI). This sometimes deadly complication is unpredictable and incompletely understood. In this proposal, we will generate new understanding of how and why TRALI occurs, potentially leading to new strategies to prevent and/or treat this disease.